Intracranial Insights into Globus Pallidus externus (GPe) Computations in Obsessive-Compulsive Disorder

PROJECT SUMMARY
Obsessive-compulsive disorder (OCD) is characterized by repetitive thoughts and behaviors, often driven by
an inability to adapt behavior in response to changing environments. The basal ganglia, a network of
subcortical nuclei, plays a crucial role in cognitive and motor processes, and imbalances between the direct
and indirect pathways of this network is implicated in OCD. The indirect pathway is hypothesized to be
hyperactive in OCD, leading to excessive suppression of behavioral flexibility. This hyperactivity may underlie
the hallmark compulsive and repetitive behaviors seen in OCD, which can be interpreted as an over-reliance
on habitual associations, effectively "locking" patients into rigid behavioral states This project aims to
investigate the role of the external part of the globus pallidus (GPe), a key node in the indirect pathway of the
basal ganglia, in compulsive choice behavior. By leveraging intracranial single-unit recordings in OCD patients
undergoing deep brain stimulation (DBS) surgery, this study will assess how neural activity in the GPe
contributes to adaptive and maladaptive decision-making during a reversal learning task. The goals of this
study are twofold: (1) characterize the role of the GPe in adaptive and maladaptive decision-making in OCD,
and (2) determine the computational contributions of GPe to the basal ganglia indirect pathway using single-
unit recordings during reversal learning. Specifically, we hypothesize that neural activity in the GPe will be
modulated during changes in choice selection ("switch" versus "stay" conditions), with increased firing rates
observed during switch conditions. Additionally, we predict that GPe activity will differ based on the outcome
valence of decisions (positive, negative, and neutral results). We will also test the hypothesis that reward
prediction errors and choice confidence, estimated using reinforcement learning and Bayesian models,
respectively, will be correlated with GPe firing rates. By addressing these aims, this project will generate novel
insights into human GPe signaling, which has never before been recorded, offering a unique perspective on
the neurobiology of compulsive behaviors. Ultimately, these findings may lead to new therapeutic targets for
OCD, improving our understanding and treatment of this debilitating disorder. This research will also provide
the applicant with comprehensive training in computational modeling and human electrophysiology, preparing
her to become a leader in computational psychiatry.

Public health relevance
PROJECT NARRATIVE The basal ganglia, critical for sensorimotor and cognitive control, are implicated in compulsive disorders like OCD through dysfunction in the indirect pathway. This study will use single-unit recordings during reversal learning to (Aim 1) characterize the role of the external segment of the globus pallidus (GPe) during adaptive and maladaptive decision-making in OCD, and (Aim 2) determine the computational contributions of GPe within the basal ganglia indirect pathway. Our findings will include novel insights into human GPe function, which has never before been recorded during cognitive tasks, potentially leading to the identification of new therapeutic mechanisms for treating OCD.